RFA-PS-23-001 - Project PrOVIDE: PrEP Optimization Via Implementation, Dissemination, and Evaluation

PROJECT SUMMARY
Significant disparities in pre-exposure prophylaxis (PrEP) for HIV prevention exist in the U.S. with cisgender
women making up a disproportionately low percentage of PrEP users compared to men. 60% of new HIV
diagnoses among women are among Black cisgender women. Challenges exist at each step of the PrEP care
continuum, including difficulty identifying Black cisgender women at highest risk for HIV who are most likely to
benefit from PrEP, women’s own low self-perception of HIV risk, low levels of PrEP knowledge, and barriers to
PrEP initiation and persistence. While there has been growing knowledge of interventions to increase PrEP
use among men who have sex with men and transgender women, much less is known about successful
implementation strategies to increase uptake and support PrEP persistence among Black cisgender women.
Our team’s preliminary mixed methods work identified PrEP implementation strategies for Black cisgender
women consisting of: routine PrEP education for patients, standardized provider training, electronic medical
record tools, PrEP navigation, clinical champions, and mHealth tools. We propose to adapt, implement, and
evaluate the impact of these strategies to improve PrEP care continuum outcomes for Black cisgender women
across six counties in the U.S. using implementation science research methods. PrEP implementation planning
will guide strategy selection and identification of new implementation strategies. Our team proposes the following
aims: AIM 1: Identify, select, and adapt implementation strategies for engaging Black women in the PrEP care
continuum in six clinic settings in EHE priority areas (midwest, north, south). AIM 2: Determine the effectiveness
of PrOVIDE implementation strategies on PrEP uptake among Black cisgender women across six clinic sites via
a hybrid type II study design. AIM 3: Assess and document implementation outcomes and report on key barriers
and facilitators related to successful implementation of the implementation strategies using the RE-AIM
framework.

Public health relevance
PROJECT NARRATIVE Black women experience one of the highest incidences of HIV among all U.S. subpopulations and despite national PrEP implementation efforts, uptake among Black women remains low with only 10% who could benefit from PrEP prescribed it in 2020. Given the 2021 PrEP guidance to inform all sexually active patients of PrEP and 2022 FDA approval of cabotegravir injections, it is essential that health systems implement interventions to increase PrEP uptake and improve persistence among Black women. Project PrOVIDE: PrEP Optimization Via Implementation, Dissemination, and Evaluation will evaluate implementation strategies to address barriers and increase uptake of and persistence on PrEP among Black cisgender women in six distinct counties.